DESIGN OF ANTI HIV 1 RIBOZYME DRUG BASED ON 3D STRUCTURE

Among the various therapeutic agents currently being developed for the treatment of AIDS pathogenesis, catalytically active RNAs targeted to RNA genes and gene products of HIV-1 and other associated opportunistic pathogens are one of the most promising approaches. This project addresses the rational design of a catalytically efficient, nuclease resistant ribozyme targeting a particular, single site in the HIV-1 RNA.